Optimizing Rho-associated kinase inhibitors for use in treating Fuchs endothelial corneal dystrophy

PROJECT SUMMARY/ABSTRACT
Fuchs endothelial corneal dystrophy (FECD) is a polygenic disease that affects 6.1 million Americans over
40 years of age and is the leading indication for corneal transplant surgery in the U.S. FECD is diagnosed based
on visible damage to corneal endothelial cells (CECs) and degenerative extracellular matrix deposits on the inner
cornea (guttae). FECD pathogenesis is characterized by CEC dysfunction, endothelial-to-mesenchymal
transition (EMT), extracellular matrix (ECM) degeneration, and CEC death that lead to vision loss. Although it
can be diagnosed early, FECD requires corneal transplantation for vision loss because there are no therapies to
prevent its progression. We found previously that the Rho-associated kinase inhibitor (RKI) ripasudil decreases
FECD phenotypes, warranting an exploration of its potential as a possible therapeutic option to prevent
transplantation. Currently, two RKIs (netarsudil and ripasudil) are being used as adjuvant therapies to accelerate
endothelial wound healing in Descemetorhexis without endothelial keratoplasty (DWEK). Studies have not yet
been performed comparing these two RKIs head-to-head. Problems with RKI treatments include ocular irritation
and frequent dosing requirements. Additionally, RKIs have not been tested as a preventative for FECD
progression. The overall objectives of the proposed research are to determine the relative efficacy of two RKIs
(netarsudil and ripasudil) for use in two distinct applications for the treatment of FECD (DWEK, primary drug
therapy to prevent FECD progression). Our central hypothesis is that netarsudil and ripasudil will have equivalent
efficacy in wound healing and FECD phenotype reversal, and that packaging RKIs into targeted nanoparticles
(NPs) will decrease off-target side effects and permit reduced dosing frequency. The rationale for the proposed
research includes the following: i) head-to-head RKI comparisons are needed because if netarsudil works then
clinical use may be achieved more quickly; ii) dose-reduction and sustained-release strategies are needed
because ocular irritation limits RKI use; and iii) testing RKIs for suppression of FECD phenotypes is needed to
determine if future clinical trials are warranted. Guided by strong preliminary data, our hypothesis will be tested
through the following specific aims: 1) Determine the optimum dosing of RKIs in a FECD DWEK treatment model;
and 2) Determine the clinical efficacy and toxicity of RKIs with and without targeted NP packaging in a FECD
disease prevention mouse model. The approach is innovative in its use of a new cell culture model that makes
it possible to delineate the pathological events related to disease progression in early-onset FECD, as well as
novel nanoparticles that are capable of delivering drugs to FECD cells with more efficiency and less toxicity. The
proposed research is significant because RKI use would permit FECD treatment alternatives that do not rely on
donor corneal tissue or corneal transplantation (only 1 donor cornea is available for every 70 needed worldwide).
This proposal is of higher risk because it is unknown if RKIs can prevent FECD disease progression, but has a
high potential reward of developing drug therapy treatments that may delay or prevent surgery.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because in spite of early detection, Fuchs endothelial corneal dystrophy (FECD) inevitably progresses to vision loss requiring corneal transplantation. The proposed investigation of the use of Rho-associated kinase inhibitors in FECD would shed light on their potential efficacy in two separate clinical applications before end-stage disease develops, and thus facilitate the development of important therapeutic alternatives for treating FECD that could delay or prevent the need for surgery. Such alternative treatments are critical to develop given the high prevalence of FECD (more than 4% of the U.S. population is affected), the high frequency of requiring corneal transplant surgery (FECD is the top indication for corneal transplantation), and the worldwide shortage of donor corneal tissue (only 1 donor cornea is available for every 70 needed).